Supplement: Human Brain Collection for Study of the Neuropathogenesis of SARS-CoV-2, HIV-1, and Opioid Use Disorder

Abstract from Parent Award UM1DA051410
Opioid use disorder (OUD) and HIV infection are syndemic conditions that independently and
synergistically lead to central nervous system (CNS) dysfunction in tens of millions of people globally.
However, the cellular circuits altered by OUD and HIV, and their combination, remain elusive. Further, the
identities of cell types within the brain that can harbor HIV infection remain controversial. To address this
key vexing question of HIV location within the brain and the effects of HIV and OUD on the brain,
comprehensive tissue characterization at the single-cell level is needed to identify novel rare cell types,
enriched or depleted cellular populations, and cellular circuits tied to pathogenesis. We propose to employ
state-of-the-art methodologies in a center at Yale devoted to generating data on Single Cell Opioid
Responses in the Context of HIV Discovery (SCORCH), Y-SCORCH. The center assembles a team of
investigators at Yale with leading expertise in neurogenomics, HIV biology, neuroscience of addiction,
single-cell analytics and consortium science, and a record of existing collaborations. Our TISSUE
Component includes plans to sample 20 brains from four donor groups: controls, HIV (HIV+), HIV with
OUD (HIV+OUD+), and OUD without HIV (OUD+). For each brain we will study 4 regions (prefrontal
cortex, ventral striatum, insular cortex, and amygdala), representing disease-relevant areas for OUD and
HIV. Our ASSAY Component will carry out single nucleus RNA sequencing (snRNA-seq) for 5,000-20,000
cells/sample, single-nucleus ATAC-seq (scATAC-seq), and spatial transcriptomics to generate
transcriptomic, epigenetic, and spatial atlases for each donor type and each region. In parallel, we will
detect HIV transcripts in the HIV+ groups. Our DATA Deposition & Analysis Component will assemble
data standards, facilitate dissemination, and integrate our data with existing brain atlases. It will develop
pipelines for high-throughput data analysis, including for single nucleus transciptomes, detection of HIV
transcripts and for scATAC-seq data and develop innovative analysis methods. Our Prioritization &
Functional VALIDATION Component proposes a process of identification of brain regions and donor
types that best differentiate disease states, and describes experiments to validate the findings generated by
transcriptomic and epigenetic analyses. Finally, our Research MANAGEMENT Component provides a
framework for data sharing with the SCORCH Data Center and broader Consortium and ensures timely
progress in achieving our milestones which include generating `omics data from 640 assays. Our Specific
Aims are to: (1) Establish a workflow from tissue samples to single-cell data deposited in the data center,
(2) Run the combined experimental and computational workflows on procured specimens, and (3) Follow
up on large-scale data production with validation and further analysis. Y-SCORCH has established
expertise in all approaches necessary to successfully create single-nucleus transcriptomic data to provide a
scaffold for future discovery to inform pathophysiological understanding of CNS effects of OUD and HIV.

Public health relevance
Narrative from Parent Award UM1DA051410 Opioid use disorder (OUD) and HIV infection can affect cognition and behavior both independently and in combination, but knowledge is limited regarding how brain cells and circuits are altered in association with these conditions. Furthermore, HIV can persist in the brain long term, though the precise cellular locations of HIV infection and whether this infection is worsened by coexistent OUD and HIV are also unknown. The work proposed in this application will help determine which cells and which areas of the brain are involved in these conditions separately and together, thus improving our understanding of the brain effects of OUD and HIV.